Developmental Research Program

PROJECT SUMMARY/ABSTRACT
The Developmental Research Program (DRP) of the Pacific Northwest (PNW) Prostate Cancer SPORE is de-
signed to solicit, evaluate, and support innovative pilot projects in translational prostate cancer research. Projects
funded under the DRP are intended to rapidly advance a new idea or concept that has the potential to substan-
tially impact our understanding of prostate cancer, and ultimately influence the clinical management of this dis-
ease through improved prevention and treatment strategies. Since the inception of the PNW Prostate Cancer
SPORE, the infrastructure of the DRP has established mechanisms to quickly respond to translational research
opportunities within the PNW SPORE institutions that require support to advance hypotheses or confirm feasi-
bility in order to justify larger resource investments. Developmental projects include research in basic science,
clinical science, and population-based studies, and will continue to build collaborations between PNW SPORE
sites and other institutions with SPOREs in prostate cancer.
The Specific Aims for the Developmental Research Program are to:
1. Stimulate the development of innovative, impactful early-phase research studies that include multi-discipli-
nary interactions with basic, clinical, and population scientists across the PNW Prostate SPORE institutions
and including inter-SPORE collaborative studies;
2. Provide funding (1-2 years) and infrastructure (e.g., biospecimens, biostatistical support) to rapidly test the
feasibility of original investigator-initiated projects in all areas of PC research;
3. Prioritize funding to rapidly exploit new opportunities or support specific areas of strategic importance for
advancing the translational research goals of the PNW Prostate SPORE;
4. Advance early stage scientific research that addresses prostate cancer health disparities and promote re-
search directed by scientists from underrepresented minority groups; and,
5. Monitor (and facilitate) the progress of each DRP project and consider their advancement to a full SPORE
project.